Progression and differential control of postural and kinetic tremor with deep brain stimulation

Abstract
Essential Tremor (ET), despite being the most common movement disorder affecting 4% of adults over age 40,
remains relatively understudied in terms of its pathogenesis, neurophysiology, clinical classification, and
optimization of treatments on a patient-specific basis. For the 25-55% of medication-refractory patients whose
symptoms have become functionally limiting, surgical management is recommended, most commonly with deep
brain stimulation (DBS). However, despite recent advances in DBS lead technology, controversy exists over the
optimal target, side effects occur frequently, and up to 73% of patients experience loss of benefit over time. As
a result, there is a clear need for refinement and deepened understanding of optimizing treatments for ET. This
project will leverage an ongoing prospective clinical study in human patients diagnosed with ET and
implanted with directional DBS leads, integrating high-field magnetic resonance imaging, patient-
specific pathway activation modeling of DBS, quantitative sensors, and comprehensive
electromyography measurements to further understand the neural and muscular mechanisms behind
tremor control and progression. Specifically, Aim 1 will identify the cerebello-thalamo-cortical pathways
involved in kinetic and postural tremor control with directional DBS leads, pathway activation optimization
algorithms, and quantitative sensors. Aim 2 will approach identifying the underlying mechanisms of tremor control
from the peripheral muscular end using whole-body electromyography. Finally, Aim 3 will determine how
tolerance to stimulation, disease progression, or lead placement contribute to long-term DBS failure in tremor
control. While DBS can result in improvement of clinical tremor scores, physicians still have trouble capturing
action tremor in the short-term and maintaining therapeutic benefit in the long-term. Understanding the pathways
contributing to tremor and to side effects via a model-based, patient-specific programming approach would allow
for improved and more consistent control of patients’ symptoms with DBS therapy.

Public health relevance
Narrative While deep brain stimulation (DBS) does offer symptom relief for most patients with Essential Tremor (ET), DBS therapy is not as effective at reducing tremors during voluntary movement and has been shown to lose effectiveness over time. Understanding of the neural, muscular, and failure mechanisms underlying tremor control and progression with DBS could help combat these therapeutic challenges and result in improved patient outcomes. This project will integrate high-field magnetic resonance imaging, patient-specific pathway activation models of DBS, quantitative sensors, and comprehensive electromyography measurements to further understand the mechanisms behind tremor control, tremor progression, and side effect induction with DBS.